Risk and Protective Factors for E-cigarettes Among Adolescents, Young-Adults, and Adults and Across Two Generations

This 3-year R01 proposal will examine socio-developmental and demographic risk and protective
factors that characterize e-cigarette (e-cig) users, explore the concomitant use of e-cig and conventional
cigarettes (cigarettes), and investigate intergenerational transmission of e-cig use and norms. Analyses will 1)
identify which risk and protective factors are most predictive of e-cig use among adolescents, young adults,
and adults, explore how these factors differ from tobacco risk factors and by gender and ethnicity; 2) examine
the interplay of tobacco products and e-cigs, examine whether cigarette use leads to e-cig and vice versa,
whether they hinder cessation attempts among smokers, and whether using e-cigs is associated with more
positive norms toward tobacco; and 3) explore the degree to which parent e-cig use and norms are associated
with child use and positive norms for e-cigs and cigarettes, and pose a risk for child use of other substances.
The proposed project is uniquely suited to address these aims. It builds on three existing longitudinal
studies: The Seattle Social Development Project (SSDP), The Intergenerational Project (TIP), and the
Community Youth Development Study (CYDS). SSDP participants (n = 808) have been followed since age 10
(1985) and have been interviewed 14 times. The most recent data collection at age 39 (2014) included
measures of e-cig use. TIP has followed SSDP participants who have become parents, their first-born child,
and another caregiver (N = 412 families) since 2002 using an accelerated longitudinal design (child age 1 - 28
years, N = 315 have been interviewed during adolescence between ages 10-20). Parents and children have
been interviewed eight times; two additional waves of data, including e-cig items, will be collected in 2017 -
2018 (funded separately). CYDS is a longitudinal panel of youth (n = 4,407; control group n = 2,002) from 24
communities across seven states which began in 2003. Participants have been interviewed 10 times from ages
10 through 23 (2016). Data at ages 21 and 23 contain e-cig modules.
The proposed project is informed by the Social Development Model and accumulated knowledge about
the risk and protective factors for tobacco use from the literature. The current study brings needed longitudinal
investigations that span multiple developmental periods, prospectively measured tobacco use history, and the
ability to look at the intergenerational transmission of e-cig use and norms. Data from these three datasets will
provide insight into identifiable characteristics of e-cig users, their impact on tobacco use among adolescents
(TIP children), young adults (CYDS), and adults (SSDP, TIP parents), as well as the relationship between
parent and child e-cig use (TIP). By using existing longitudinal studies, the current proposal is innovative, cost-
and time-effective, and is uniquely positioned to rapidly address critical gaps in our understanding of e-cigs.
Findings form this study will yield viable targets for prevention and direct implications for policy and regulation.

Public health relevance
The rise in e-cigarette popularity has outstripped the pace of research, and could pose a significant threat to the downward trend in conventional tobacco use. The proposed study will leverage existing longitudinal data in order to a) examine risks and protective factors for e- cigarettes for adolescents, young adults, and adults, b) examine whether these differ from those of conventional tobacco products, and by gender, ethnicity, and developmental period; b) test whether e-cigarettes pose a risk to initiation or continued use of conventional cigarettes and vice versa; and d) explore the degree to which parent e-cigarette use increases the risk of child tobacco use. Results will provide clear direction for e-cigarette prevention, policy, and regulation efforts.